Signal transduction, metabolic shifts, and host interactions during group B Streptococcus infection

Project Summary
Group B Streptococcus (GBS) is a pathobiont that causes dangerous infections during pregnancy and in
the neonatal period. The goal of our proposed project is to determine molecular mechanisms that cause fetal
injury, preterm labor, and stillbirth during GBS intraamniotic infection. The scientific premise of our work stems
from the fact that GBS is a common and asymptomatic commensal member of the intestinal microbiota in up to
30% of healthy adults, yet when GBS transits to the intraamniotic space it demonstrates host cell invasiveness,
cytotoxicity, and pro-inflammatory characteristics that can be catastrophic to pregnancy viability. We
hypothesize that significant drops in micronutrient availability that occur when GBS moves from its colonizing
niche in the intestine and vagina into the nutritionally austere environment of amniotic fluid activate cellular
stress responses that promote expression of virulence factors and drive adverse pregnancy outcomes. This
nutritional virulence hypothesis is supported by multiple studies published by our group, which point to small
molecule byproducts of nucleotide synthesis pathways—upregulated during host invasion—as molecular
mediators of the GBS phenotypic shift from commensal to virulent in amniotic fluid. Our own preliminary data
are further supported by evidence from other, independent laboratories, whose findings conform to a model of
shifting bacterial metabolism as a signaling event that promotes GBS virulence. Our multi-institutional, multi-
disciplinary consortium will deploy a unique set of experimental capabilities to examine how environmental
growth conditions interact with genetically encoded stress responses to produce distinct metabolomic profiles
in GBS. Through three specific aims, we will 1) determine the impact of the GBS metabolome on expression of
known virulence factor pathways; 2) evaluate how altering the GBS metabolome affects its propensity to
invade and inflame human fetal membranes; 3) use direct intraamniotic injection in a mouse model of
gestational GBS infection to assess in vivo the impact of altered GBS metabolic states and signaling molecule
production on clinically relevant pregnancy outcomes of fetal demise and preterm delivery. These studies will
establish a new paradigm for understanding a consequential infectious cause of pregnancy loss worldwide,
generating translatable insights into mechanisms of intraamniotic infection by GBS.

Public health relevance
Project Narrative The goal of this research project is to understand why group B Streptococcus (GBS), a type of bacteria that causes severe pregnancy complications such as stillbirth and preterm labor, can be harmless in the gut and vagina of healthy adults yet catastrophically dangerous in the amniotic fluid surrounding a fetus. We hypothesize that when GBS moves into the amniotic fluid, it experiences a lack of essential nutrients that are typically present in the digestive and vaginal tracts, and that this nutrient deprivation activates bacterial stress responses. These stress responses may include increased expression of harmful molecules that trigger the maternal and fetal immune system, ultimately causing tissue damage and threatening the pregnancy. These studies may help us better understand and prevent GBS-related pregnancy complications.